Reprogramming of mature SMCs to vascular progenitor cells: Focus on Vascular Fibrosis

ABSTRACT
Excessive perivascular fibrosis results from the highly dynamic and dysregulated process of normal tissue repair
and is defined by the excessive accumulation of extracellular matrix (ECM) material resulting in decreased
vascular compliance and increased vessel stiffness. In contrast, a fibrotic response is critical to the formation
and stability of a fibrous cap in the setting of atherosclerosis. While advances have been made in our
understanding of fibrosis pathobiology, significant gaps remain. In particular, while mesenchymal cells with the
potential to transition into activated myofibroblasts are believed to be key sources of excessive ECM deposition,
their origin remain debated. Using cell-specific lineage tracing and RNA sequencing, our group made the
paradigm-shifting discovery that a subpopulation of resident vascular stem cells residing within the vascular
adventitia originate from mature vascular smooth muscle cells (SMC)(termed AdvSca1-SM cells). SMC
reprogramming and AdvSca1-SM cell maintenance is dependent on induction and activity of the transcription
factor, Klf4. In contrast, vascular injury-induced or AdvSca1-SM cell-specific genetic Klf4 depletion promote the
transition to profibrotic myofibroblasts, which consequently serve as major contributors to perivascular fibrosis.
However, the molecular mechanism whereby Klf4 dictates the maintenance and differentiation of AdvSca1-SM
cells remains unclear. Leveraging a highly specific AdvSca1-SM cell reporter system and single-cell RNA-
sequencing (scRNA-seq), we demonstrate the profibrotic differentiation trajectory of AdvSca1-SM cells.
Differentiation is characterized by loss of Klf4 and its downstream effector PI16, a negative regulator of the
epigenetic protein, histone deacetylase 1 (HDAC1), and the lncRNA, Meg3, but gain of expression of a profibrotic
phenotype. Importantly, these changes were recapitulated in human fibrotic tissue, underlying the translational
significance. Statin treatment was previously shown to reduce tissue fibrosis; however, the molecular mechanism
is unknown. Querying Connectivity Map database with gene signatures of AdvSca1-SM cells and their profibrotic
derivatives indicate that statins are potential candidates to antagonize the profibrotic transition of AdvSca1-SM
cells. Finally, while inflammation and fibrosis drive the wound healing process in most adult mammals, scarless
regenerative wound healing in adult rodents of the species Acomys has been reported. Our recent findings show
a complete absence of fibrosis with rapid regeneration in two models of kidney injury in Acomys. Here, we
propose a novel concept that a Klf4-Meg3 axis plays a central role in the maintenance of the stem cell phenotype;
loss of Klf4 and/or Meg3 activates a signaling cascade facilitating the phenotypic transition of AdvSca1-SM (Aim
One). Further, we propose that Acomys is resistant to pathological vascular remodeling and fibrosis in part due
to activation of an AdvSca1-SM-specific regenerative gene expression signature (Aim Two). Finally, statin
treatment will inhibit or reverse the profibrotic transition of AdvSca1-SM cells (Aim Three).

Public health relevance
PROJECT NARRATIVE/PUBLIC HEALTH RELEVANCE Perivascular fibrosis, which is the progressive accumulation of non-cellular extracellular matrix, decreases normal vascular function and increases vessel stiffness. The studies in this proposal focus on the contribution of a unique population of resident vascular stem cells in the development of fibrosis as these cells lose their stemness phenotype and switch to a phenotype for producing matrix in the setting of vascular disease. We aim to define the mechanisms that control the phenotype of these vascular stem cells in the setting of vascular disease, to define the response to vascular injury and the role of these stem cells in a novel adult mouse model that demonstrates remarkable wound healing without fibrosis, and to define the anti-fibrotic effect of statins using cultured cells and mouse models of vascular fibrosis, which will lead to highly translatable findings that guide the clinical application of statins in the treatment and prevention of fibrotic diseases.